Development of Robust Corneal Biomechanical Biomarkers for Glaucoma Using Brillouin Microscopy

Project Summary:
While elevated intraocular pressure (IOP) is the only modifiable risk factor for glaucoma, up to
one third of patients have glaucoma at normal IOPs and patients with ocular hypertension may
have high IOP for years without any detectable glaucoma damage. This is in part because, in
biomechanical terms, the IOP describes the applied force or stress applied to the ocular tissues
but not the effect of the applied force, the deformation or strain. Differences in intrinsic
biomechanical properties of collagenous ocular tissues may explain the difference in response
to the stress of IOP. While prior work has shown some differences in the corneal biomechanical
properties between glaucoma subjects and controls, the widespread adoption of corneal
biomechanics as glaucoma biomarkers has been hampered by the limitations of current
technologies. Specifically, the currently used modalities rely on mechanical perturbations of the
cornea which give variable results that are confounded by IOP. The rationale underlying this
proposal is that Brillouin microscopy, a highly precise, IOP-independent, and more direct
method for determining corneal biomechanics, will improve our understanding of glaucoma
biomechanics and that its use will result in robust biomarkers for the disease. In Specific Aim 1,
we will compare the Brillouin corneal modulus in a cross-sectional study of primary open angle
glaucoma (POAG) patients and age-matched controls. We hypothesize that the Brillouin
corneal modulus will be significantly lower in eyes with POAG, indicating a cornea that is less
stiff. In Specific Aim 2 we will conduct a longitudinal study to assess the effect of short-term use
of topical prostaglandin analogs (PGA) on the corneal modulus in POAG patients and controls.
We expect that PGA use will result in a reduced corneal modulus (i.e. a decrease in corneal
stiffness), which has important implications in terms of assessing the IOP targets and treatment
success after use of PGAs. We plan to use the results of this study as preliminary data for a
larger, longer-term, and more comprehensive study to establish corneal biomechanics as robust
biomarkers for the disease.

Public health relevance
Narrative Eye pressure and its effect on the eye wall are among the most important factors that cause vision loss and ultimately blindness due to glaucoma. The goal of this project is to use a new technology to determine the effect of eye pressure on the eye wall and to develop sensitive new biomarkers to detect and guide treatment for glaucoma. This would allow for earlier intervention to prevent vision loss, provide future direction for developing new treatments, and aid in monitoring progression of disease.